Cellular and molecular determinants of amniote regenerative potentials.

A branch of the regenerative sciences looks to non-mammalian species with hyper-regenerative abilities for
clues to improve human wound healing. However, this approach has struggled to (1) select appropriate model
species for meaningful translation to humans and (2) identify specific, actionable molecular targets for
manipulating regenerative capabilities. Lizards are the only adult amniotes and closest relatives of humans able
to suppress fibrosis and regrow multiple tissue types following appendage amputation. This extraordinary
process involves formation of specialized regenerative structures known as blastemas, collections of
reprogrammed fibroblasts that differentiate into replacement tissues. Interestingly, not all lizard species are
capable of appendage regrowth, distinguishing lizards as the only group of tetrapods to contain both regenerative
and non-regenerative species. My lab has committed to studying singular lizard species that have evolved to
lack tail regeneration capabilities as natural losses-of-function models toward understanding the fundamental
requirements for blastema development. We hypothesized that losses of regenerative capabilities during lizard
speciation are due to mutation accumulations within genetic regions responsible for regulating critical aspects of
fibrosis suppression and/or blastema establishment. Consequently, we conducted inter-species hybridizations,
phylogenomic sequencing, and CRISPR screens to successfully identify mutation signatures significantly
associated with loss of blastema formation capabilities. These studies identified three candidate wound healing
processes dysregulated in non-regenerative lizard species, and each of the independent yet synergistic projects
proposed here investigates the roles of these processes in blastema formation. Project 1 focuses on
immunomodulations of pro-inflammatory signals that result in fibrosis suppression. Project 2 investigates pro-
regenerative programs that support stem cell survival, proliferation, and activation within wound environments.
Project 3 focuses on the epigenetic changes that establish wound site proximodistal patterning essential for
proper blastema formation. Successful completion of the proposed projects will meet our short-term goals of
characterizing and correcting mutations affecting key wound healing processes in non-regenerative lizard
species. The invaluable experience gained during the course of these projects will directly propel my lab toward
fulfilling our longer-term goals of inducing nature’s first blastemas in naturally non-regenerative lizard species.
My envisioned research program views these endeavors as “steppingstones” for bridging specific gaps in wound
healing capabilities between lizards and mammals. A blueprint for supporting lizard-like healing capabilities will
be applied to established models of non-regenerating mammalian injuries, such as proximal mouse digit
amputations. Ultimately, these lines of research will be applied to forming blastemas in human patients, holding
promise to limit painful scarring, support organized tissue growth, facilitate prosthesis attachment, and bring
much-needed improvements to patient quality of life following amputation injuries.

Public health relevance
Lizards are the closest relatives of humans capable of multi-lineage appendage regrowth and represent a highly relevant model for identifying actionable targets towards enhancing amniote tissue regeneration. Interestingly, singular lizard species have lost their hyper-regenerative capabilities, and we have developed a unique experimental platform involving hybridizations between regenerative and non-regenerative lizards with the specific goals of studying molecular and cellular determinants of scar inhibition, blastema formation, and wound healing. Successful completion of this proposal will answer several longstanding questions in the regenerative sciences and identify therapeutic avenues for functionally improving healing outcomes following amputation of amniote appendages.